Increasing synaptic PSD-95, a neuroprotection approach against Alzheimer's disease

Project Summary/Abstract
The first change in the brains of patients with Alzheimer’s and the best biomarker of the disease is synaptic loss.
Several studies have shown that PSD-95 (a major scaffolding protein at the synapse) is significantly depleted in
brain tissue from patients with Alzheimer’s as well as in neurons exposed to Aβ. Our data indicate that elevated
synaptic PSD-95 blocks Aβ-induced synaptic depression. The amount of synaptic PSD-95 is controlled by a
process called ‘palmitoylation’ which mediate the insertion of PSD-95 in post-synaptic membranes. Using a
commercially available inhibitor of PSD-95 depalmitoylating enzyme, Palmostatin B, we showed that this drug
could rescue Aβ-mediated effects on dendritic spines in vitro. In female APP/PS1 mice, we found that in the
hippocampus, palmitoylated PSD-95 was significantly lower than in WT littermates while total PSD-95 levels
were barely affected. Importantly, Palmostatin B injections in the intraperitoneal cavity rescued this effect in a
dose dependent manner, indicating that this drug can access brain synapses in vivo. The key focus of the parent
grant is thus to test the potential of a novel drug target, PSD-95 depalmitoylating enzyme, as a new therapeutic
avenue against Alzheimer’s disease (AD). To do so, we proposed several different experiments, some of which
were completed in the first 3.5 years of the grant. However, some key experiments still need to be completed
and due to unforeseen circumstances, require this Administrative Supplement. In some of the research described
in Aims 1 and 2, fluorescence lifetime imaging (FLIM) experiments were proposed to understand how Aβ reduces
synaptic PSD-95 (Aim 1.2), to test if increasing other synaptic scaffolding proteins can also protect synapses
from Aβ (Aim 1.3) and determine if Palmostatin B can rescue Aβ-induced changes in PSD-95 interactions (Aim
2.3). These experiments require a functional two-photon laser and our laser unexpectedly broke in September
2024. This Administrative Supplement would allow us to replace our laser, complete these key experiments and
continue to use and develop FLIM to understand molecular mechanisms in synaptic physiology as our lab is one
of the world’s leaders using FLIM in neuroscience research. Moreover, in Aim 3, we proposed behavioral
experiments to assess if Palmostatin B can rescue memory deficits in vivo. Characterizing the effect of a drug
on mouse behavior is the most convincing way of demonstrating therapeutic potential. These experiments were
planned with Dr. Rissman, a leader in AD model mouse research. Dr. Rissman unexpectedly left UCSD in June
2024, making it impossible for us to use his behavioral equipment. To complete these essential experiments, we
need to purchase our own behavioral equipment, which would be possible with this Administrative Supplement.
Importantly, all the proposed research in this Administrative Supplement request is to complete experiments
originally planned in the main grant, and thus within its scope. In conclusion, this innovative project will improve
our understanding of how synapses are affected during AD and test a pharmacological approach to make
synapses stronger from within, which would be beneficial for both treating and preventing AD.

Public health relevance
Project Narrative This project will characterize key cellular and molecular events that participate in the development of Alzheimer’s disease and identify therapeutic pathways to reverse these pathological events. We discovered that synapses containing elevated amounts of PSD-95 are protected against the detrimental effects of amyloid-beta, a peptide thought to cause Alzheimer’s disease. We will study PSD-95 in several brain regions as it might explain cell vulnerability and develop a pharmacological approach to increase synaptic PSD-95, which has the potential to open a new therapeutic avenue against Alzheimer’s.